Training Program in Immunology and Pathogenesis

This renewal application requests funds to continue a Program for predoctoral training in
Immunology and Pathogenesis. Four predoctoral positions are requested. Trainees are typically
supported for 2 years, allowing for approximately 12 trainees. The goal of the training program
is to prepare trainees for productive careers in academia, industry, or other science-related
occupations. The Training Faculty are experienced researchers drawn from multiple
departments across the Institution including Microbiology and Immunology, Molecular Medicine
and Translational Science, Biochemistry, and Physics. The Training Faculty possess a broad
array of expertise but share a strong focus on immunology and pathogenesis. This long
standing T32 Program in Immunology and Pathogenesis has clear strengths that enhance
predoctoral training, including: 1) innovative mechanisms such as the Career Development
Workshops, Training in Communicating Science to the Public, and Opportunities for Community
Engagement which enhance and add value to graduate training above that which is normally
found in a graduate program, 2) a diverse training faculty which draws from a number of
research programs throughout the Institution, 3) and a history of success in the recruitment of
URM students. The success of the Training Program is evidenced by the very strong publication
record and the high quality of subsequent postdoctoral and career positions.

Public health relevance
This renewal application requests funds to continue a predoctoral Program for graduate training in Immunology and Pathogenesis. The goal of this long standing Program is to provide value added training to prepare students for productive careers in academia, industry, or other science-related careers.